CHLORZOXAZONE 6-HYDROXYLATION IN VIVO PROBE OF CP450

Investigate cytochrome P4502E1 activity in humans using chlorzoxazone 6- hydroxylation as an in vivo probe and to identify physiological determinants and other modulating factors such as age, disease states, and drug interactions.